Building capacity for patient-centered outcomes research to improve the quality and impact of HIV care in Tanzania

Project Summary/Abstract
As a result of widespread access to effective antiretroviral treatments (ART), globally, life
expectancy for people living with HIV (PLWH) has increased substantially, nearing that of the
general population. In Tanzania, 1.7 million people are reported to be currently living with HIV.
About a third are >50 years of age, with estimations that this population will grow by 25% by
2040. The aging process is associated with molecular and cellular damage which subsequently
increase the risk for non-AIDs related comorbidities such as cardiovascular disease (CVD),
chronic kidney disease, diabetes, and cancer among aging PLWH. Persistent chronic immune
activation and inflammation that persists despite effective ART also increases the risk for these
NCDs. Age-related comorbidities including frailty, impairment in ADL, and cognitive dysfunction
are also prevalent among older PLWH and together with NCDs, which are increasingly
diagnosed at a younger age in PLWH, can significantly impact QOL. In Tanzania, the ageing
PLWH population is presenting considerable challenges for how to address prevention, and
treatment needs in these vulnerable group. Data on the current burden of geriatric and medical
co-morbidities among older PLWH and their impact on QOL in Tanzania is sparse. Identification
of these conditions is further complicated by infrequent use of screening tools adapted for
Tanzania for monitoring ageing-related co-morbidities such as frailty and cognitive functioning.
In this project, we will assess the burden of medical and geriatric comorbidities such as frailty
and cognitive dysfunction and their association with quality of life (QOL) in a cohort of PLWH
age>50 in urban Tanzania using a number of tools already validated in Tanzania and similar
settings. These data will inform subsequent qualitative interviews that will be conducted with
older PLWH reporting higher and lower QoL, to better understand and inform interventions
needed to reduce the burden of age-related co-morbidities and improve QoL. The project will
leverage resources and participants from an existing research cohort of ALHIV that was
established by Dr. Ottaru (Trainee Project Lead) to examine ideal health and CVD in 2020, and
is supported by the parent training grant. The establishment of a cohort of older PLWH will be
important for longitudinal research to understand the progression of comorbidities and
effectiveness of strategies and interventions to reduce burden, improve QoL and inform the care
needed for older PLWH in Tanzania and the region. The supplement meets the goals of the
parent D43 grant (1D43TWO10946-01A1, “Building capacity for patient-centered outcomes
research to improve the quality and impact of HIV care in Tanzania”) which is designed to build
capacity for patient-centered outcomes research in Tanzania. It will also provide the opportunity
for Dr. Ottaru to acquire news skills in the measurement of aging comorbidities, longitudinal
cohort management, mixed methods and PCOR and support her plans for pursuing funding to
become an independent researcher in HIV and aging in Tanzania.

Public health relevance
Narrative As the population of people living with HIV (PLWH) age globally, there is a need to better understand the burden of comorbidities including those related to aging, especially in low- and middle-income country settings where the highest burden of HIV exists. The goal of this supplement, embedded into our existing D43, is to use multiple methods to assess the burden of medical and geriatric comorbidities and their association with quality of life (QOL) in a cohort of PLWH age>50 in urban Tanzania and also use explanatory mixed methods to better understand factors associated with QOL. Results of this study will be important to identify priorities for interventions to address the burden of comorbidities and to improve QOL in this population while supporting development of researchers in aging, HIV and patient-centered outcomes research in Tanzania.